Metabolic basis of retinopathy of prematurity and potential treatment with anaplerotic substrates

Project summary/abstract
Supplemental oxygen is provided to premature infants to prevent mortality. Hyperoxia prevents
mortality, however, hyperoxic exposure of premature infants inhibits retinal neurovascular
development and causes retinopathy of prematurity (ROP). Findings from our work and other
groups indicate that ROP development involves deficits in liver metabolism. For example, DHA,
AA are produced in the liver, and these have been associated with the ROP. In addition, we have
demonstrated that the liver-based HIF1-α is required to produce the retinal serine/one-carbon
metabolites to prevent oxygen-induced retinopathy (OIR). Infants with low weight at birth are more
prone to ROP, implying that nutrition plays a role in ROP development. In addition, premature
infant mothers have different fat compositions in their milk. There are higher amounts of medium-
chain fatty acids (MCFAs) and long-chain polyunsaturated fatty acids (LCPUFAs) in the milk of
mothers of premature infants. Although LCPUFAs have been studied, both in the OIR model and
in ROP clinical trials, the role of energy-generating MCFAs remains unknown.
Our recent publication highlights that hyperoxia downregulates the entry of glycolytic carbon into
the tricarboxylic acid cycle (TCA cycle) and upregulates glutamine-fueled anaplerosis in the Müller
cells in response to hyperoxia. This lowers the amount of glutamine available for endothelial cell
proliferation. We hypothesize, providing a substrate that can feed into TCA, can prevent glutamine
diversion into TCA cycle. One of the top alternative substrates in the early stages of development
is MCFA from maternal nutrition. We compared the fatty acid β-oxidation genes in the retina. We
found statistically significantly higher expression of only MCFA utilization and ketone body
utilization enzymes in OIR-resistant mouse strain. Our preliminary data shows a higher availability
of MCFA octanoate in the blood of OIR-resistant strain. In addition, our liver RNAseq data
indicates higher conversion of MCFA-CoAs into free fatty acid MCFAs and ketone bodies. We
tested the utilization of medium-chain fatty acid-octanoate in the retinal explant experiments and
found increased utilization in response to hyperoxia. Altogether, our data indicate that a balance
between fatty acid utilization and nitrogen compound-based anaplerosis may be the underlying
cause of oxygen-induced retinopathy development. The Aim of this grant is to study fatty acid
metabolic exchanges between liver and retina at systems levels, and to use anaplerotic
substrates in conjunction with Adeno-associated viruses (AAVs) based genetic manipulations of
the fatty acid metabolic genes, to prevent oxygen-induced retinopathy.

Public health relevance
ROP turns 30-40000 infants blind every year. There is no treatment available to prevent vaso- obliteration in phase 1. The Aim of this proposal is to 1) find the metabolic cause of oxygen- induced retinopathy 2) attempt to use anaplerotic substrates to treat oxygen-induced retinopathy in phase 1. This project is relevant to public health because this project will address the role of maternal diet in OIR, the role of liver-based β-oxidatoin in ROP and may also help find an efficient anaplerotic substrate to prevent OIR.